Integrated Training in Respiratory Research

Abstract
Our training program in pulmonary disease and critical care medicine provides comprehensive research
training for individuals with a serious commitment to a career in lung biology and biomedical research,
particularly as it interfaces with clinical pulmonary and critical care medicine. Lung diseases comprise a major
source of excess morbidity and mortality worldwide, so our primary premise is that progress toward improved
understanding of the pathobiology of these diseases is required to make progress toward treatment and
prevention. The program has a long history (>30 years) of training numerous physician-scientists and scientists
who have subscribed to this mission and have become leaders in academic pulmonary and critical care
medicine. No changes are anticipated in the program leadership structure. We plan to maintain the previous
scientific and training success, while adapting the next generation of researchers to the constantly changing
state-of-the-art of basic and translational science. Recent changes have included expanded resources
(recruitment of new faculty members, and increased laboratory space) and development of the Brigham
Research Institute’s Lung Research Center. This has allowed us to broaden the scope of research questions
related to lung biology and attack problems at the most basic and translational levels incorporating new core
resources. We have continued to enhance our didactic program and further solidify program organization for
oversight and mentoring of trainees. We identify trainees with a demonstrated interest in and commitment to a
research career, help them locate a training environment to pursue a problem of interest and in which creative
and rigorous thinking combined with state-of-the-art technology is being used to pursue the problem, and
provide them with the tools and mindset to attack related problems in the future. Finally, we provide a
prolonged period of support so that trainees are prepared to ultimately become productive independent
investigators, and future leaders in academic pulmonary and critical care medicine. Of the 40 trainees who
have completed the program over the last decade, 38 (95%) remain in academic medicine or research.
Moreover, of the 40 trainees who have completed the program, our trainees have been awarded 46 grant
awards (Table 8C) consisting of 24 NIH mentorship awards (18 K awards and 6 F32 NRSA), 1 DOD career
development award, 3 independent R-awards, 1 Site PI for a UG3, 3 Parker B. Francis awards, and 13
foundation awards (Harvard Catalyst KL2, Pulmonary Fibrosis Foundation, American Heart Association,
American Lung Association, LAM Foundation, PCORI, American Thoracic Society, AstraZeneca, Peabody
Foundation, and Stork Fund).. In addition, our T32 appointed trainees have published 324 papers with their
training grant mentors as co-authors. The Program Director and Associate Program Directors of this training
program will continue to work with the utmost enthusiasm and energy to ensure that the trainees will continue
to excel and contribute significantly to the academic pulmonary community.

Public health relevance
Narrative This pulmonary training program in basic science and clinical/translational research provides comprehensive training for individuals with a serious commitment to a career in biomedical research focused on lung disease and critical care medicine. Our primary goals are to train the next generation of physician-scientists and scientists to become independent researchers in academic medicine, better understand the pathogenesis of lung disease and identify new therapeutic modalities for lung disease.